DP24-004, Core - NYU-CUNY Prevention Research Center

PROJECT SUMMARY/ABSTRACT
Racial and ethnic minoritized immigrant communities experience disproportionately higher rates of morbidity and
mortality from type 2 diabetes (T2D), cardiovascular disease (CVD), and other chronic diseases than individuals
born in the United States. Immigrant populations face significant challenges accessing healthcare and engaging
in health-promoting behaviors due to barriers related to social determinants of health (SDOH). The NYU–CUNY
Prevention Research Center (PRC) has developed effective approaches to improve access to care and reduce
chronic disease disparities in partnership with immigrant and minoritized populations in urban settings. Since
2009, the PRC has played a leading role in generating, translating and adapting evidence-based interventions
(EBIs), with a focus on effective models of community health worker (CHW) interventions. The PRC is
an innovative and successful public–private partnership between a CEPH-accredited, minority-serving public
school of public health (CUNY) and a leading academic medical school with a 15-year history of leadership in
the national PRC Network (NYU). In the next cycle, the NYU–CUNY PRC Center will 1) expand and sustain its
infrastructure and agenda to accelerate translation of chronic disease research evidence into policy and practice,
2) engage cross-sectoral partners to support translation of research findings into practice and widespread
adoption of EBIs, 3) facilitate bi-directional training and technical assistance across partners and PRC networks
to support translation of prevention research, and 4) disseminate research findings and translation products. For
the PRC's core research project, we propose a type 2 hybrid implementation-effectiveness trial to test a multi-
level implementation strategy that addresses key community-, clinic-, and patient-level barriers to uptake and
adoption of diabetes self-management education and support (DSMES). We test: 1) a CHW-enabled community-
clinic linkage (CCL) model across a network of federally qualified health centers and community-based
organizations to improve clinical coordination and address social needs, followed by 2) a series of 24 culturally
and linguistically tailored DSMES videos delivered by text message (mhealth) to improve knowledge, skills, and
self-efficacy to manage T2D. We will test this multi-level strategy for DSMES uptake among low-income Hispanic
and Asian immigrant adults with T2D. We will 1) identify facilitators/barriers to the implementation process and
assess patient uptake of specific DSMES delivery strategies (primary implementation outcome); 2) examine the
effectiveness of CHW-enabled CCL on reducing HbA1c at 6-months and the effectiveness of additional mhealth
on sustaining glycemic control at 12-months (primary effectiveness outcome); and 3) assess and improve the
sustainability and scalability of the package using participatory system dynamics modeling. Finally, the NYU-
CUNY PRC will support the national PRC network to: 1) engage policymakers around SODH and health
outcomes; and 2) adapt, implement, and translate EBIs. Our Center harnesses population health resources and
prevention science expertise, and builds upon partnerships to reduce T2D and other chronic disease disparities.

Public health relevance
PROJECT NARRATIVE Established in 2009, the NYU–CUNY Prevention Research Center (PRC) has developed effective approaches to improve access to care and reduce disparities in type 2 diabetes and other chronic diseases, in partnership with immigrant and minoritized populations in urban settings. During the next 5 years of funding, the PRC will continue to play a leading role in generating, translating and adapting evidence-based interventions (EBI) to reduce chronic disease disparities, with a particular focus on advancing knowledge on effective implementation and dissemination of community-clinical linkage models that include community health worker (CHW) and digital health interventions. For its core research project, the PRC will test a multi-level implementation strategy that addresses key barriers to adoption of diabetes self-management education and support (DSMES) among low- income Latino and Asian immigrant adult populations.